THERAPY OF CHOLESTEROL DEFECT IN SMITH LEMLI OPITZ SYNDROME

SML Syndrome is an autosomal recessive disorder which causes congenital abnormalities, severe failure to thrive, and significant mental retardation. We have recently described a defect in cholesterol biosynthesis in patients with SLOS at the penultimate step in cholesterol production, causing markedly reduced cholesterol levels and accumulation of abnormal cholesterol precursors, particularly 7-dehydrocholesterol (7-DHC). This is a newly described metabolic error in humans.